Sexual Dimorphism Among Glia in the Nervous System

PROJECT SUMMARY/ABSTRACT
The nervous system is sexually dimorphic: sex-specific behaviors are observed across species and disease
risk for many neurological disorders, including autism and Alzheimer’s disease, differs between males and
females. How sex-specific functions of the nervous system are established remains a fundamental question in
neurobiology. Glia are ideal candidates for driving these sex-specific functions. They promote the formation and
removal of neuronal connections, modulate neuronal activity, and most notably, exhibit sex differences in gene
expression. However, due to technical challenges in studying glia in mammalian systems, it remains unclear
how glial sex differences arise and how they affect neuronal function.
I will overcome these challenges by using an innovative model of sexually dimorphic glia in the highly
tractable nervous system of C. elegans. Specifically, I will investigate sex differences in a glial subtype called
CEPso glia. We discovered that a transcriptional reporter for a putative secreted protein (GRL-18) is expressed
exclusively in CEPso glia of sexually mature males. We determined that male-specific gene expression in CEPso
glia is controlled cell-autonomously and requires conserved regulators of sexual development, including the
timing genes lep-2/Makorin and lep-5 and the sex identity gene mab-3/DMRT. Interestingly, CEPso glia are
intimately associated with male-specific CEM neurons that begin responding to pheromones in the external
environment and mediating male mate-seeking behavior at sexual maturity. This leads to our hypothesis that
sex differences in glia promote the activation of a sex-specific circuit at sexual maturity.
In Aim 1, I will determine the molecular mechanisms that establish glial sex differences. First, I will use
single-cell sequencing approaches to comprehensively identify sexually dimorphic gene expression in CEPso
glia and other glia of the adult nervous system. Next, I will use classical genetic approaches and unbiased genetic
screens to identify novel regulatory factors that act downstream of conserved timing and sex identity factors to
initiate sex-specific changes in glia. The significance is to identify glial-specific regulators that control sexually
dimorphic gene expression. In Aim 2, I will determine whether sex-specific glial gene expression contributes to
sex-specific neuronal functions and behavior. To test this, I will assay aspects of CEM neuron maturation and
adult male mate-seeking behavior in wild type and mutant animals with feminized glia or lacking male-specific
genes, including grl-18. The significance will be to show how glia switch on sex-specific circuits and behaviors
in the adult nervous system, which can help to explain the striking sex biases observed in many neurological
disorders.

Public health relevance
PROJECT NARRATIVE Sex differences in the nervous system lead to sex-specific behaviors as well as striking sex biases in the prevalence of many neurological disorders, including autism and Alzheimer’s disease. Glia are a major cell type in the nervous system that influence the development and activity of neural circuits, and recent work shows that glia exhibit sex-specific gene expression. This proposal will investigate how sex differences in glia arise and will reveal how these changes alter the function of sex-specific neural circuits.